Structural Studies of Alternating-site Reactivity in Nitrogenase-like Oxidoreductases

Project Summary / Abstract
Nature uses protein allostery to control long-range electron flow in chemical reactions essential
for life. Metals and metal-clusters are often key components facilitating this electron transfer. A
known allosteric method for gating electron flow in metalloenzymes is alternating-site reactivity,
wherein reactivity switches from one half of the enzyme to the other upon conformational
changes. Oxidoreductases, with a core α2β2 heterotetrameric structure, are iron-sulfur cluster
metalloenzymes that employ alternating-site reactivity and can serve as an invaluable model
system to define the structural motifs and mechanisms required for metalloenzyme allosteric
regulation. In line with the NIH NIGMS Pharmacology, Physiology, and Biochemical Chemistry
mission of “improving molecular level understanding of fundamental biological processes and
discovering approaches to their control”, we propose to study two such oxidoreductases, the
nitrogenase-like dark-operative chlorophyllide oxidoreductase (DPOR) and chlorophyllide
oxidoreductase (COR), to identify how long-ranged correlated motions contribute to alternating-
site reactivity using structural biology tools. We will employ electron microscopy and small-angle
X-ray scattering techniques to examine enzyme conformational intermediates with asymmetrical
conformations.

Public health relevance
Project Narrative Protein allostery is critical for the regulation of biochemical pathways. Though a third to half of all enzymes are metalloenzymes, fundamental mechanisms for allosteric regulation of electron flow in metalloenzymes remain unknown. Oxidoreductases with a core α2β2 heterotetrameric structure can serve as invaluable model systems to define structural motifs in metalloenzyme allosteric regulation mechanisms that will shape design of vital therapeutic drugs disrupting allosteric response.